Objectively measured neighborhood greenness in midlife and late life cognitive and brain imaging outcomes for Alzheimer's disease: The Multi-Ethnic Study of Atherosclerosis

Alzheimer ’s disease (AD) affects over 5 million Americans aged 65 years and older. Neighborhood
environments that promote healthy lifestyles and exposures throughout the life course may help increase
cognitive reserve and thereby prevent AD or delay its onset. Neighborhood “greenness” (density of healthy
vegetation) is one such neighborhood characteristic that may increase physical activity, improve mental health,
reduce air pollution exposure, and increase social engagement, factors previously associated with late life
brain health. Compared to late life, the midlife may be a critical time for neighborhood environments to have a
more substantial effect, during the period prior to the start of AD pathology. While limited, the extant literature
has found that residing in greener neighborhoods in late life is associated with lower dementia risk, lower odds
of cognitive impairment and cognitive decline, and less brain atrophy, but previous studies have not
investigated neighborhood greenness from midlife in relation to late life brain health. Thus, this study aims to
determine whether 1) objectively measured neighborhood greenness during midlife is positively (i.e.,
beneficially) associated among ≥55 year olds with measures of a) global cognition, processing speed, episodic
memory and executive function (at baseline and longitudinally); and b) ventricular volume, total brain volume
from AD regions of interest, and white matter hyperintensities; 2) neighborhood greenness is more strongly
associated with the cognitive and MRI outcomes among women, non-Whites/Hispanics, and those of lower
socioeconomic status (SES); and 3) neighborhood greenness is more strongly associated with the cognitive
and MRI outcomes in neighborhoods with more racial/ethnic diversity, lower socioeconomic status, and more
forest and park space. Geocoded address data (retrospectively collected back to 1980) for 4,200 participants
from the longitudinal, population-based Multi-Ethnic Study of Atherosclerosis (MESA) will be used to create
measures of average neighborhood greenness from ages 45 to 54. Greenness will be based on the normalized
difference vegetation index (NDVI), a continuous measure calculated from satellite imagery in ArcGIS. Brain
health will be assessed with cognitive (global cognition, processing speed, episodic memory, executive
function) and brain imaging measures (ventricular volume, total brain volume in AD regions of interest, white
matter hyperintensities). Adjusted random intercept linear regression will test associations between average
neighborhood NDVI in midlife and the late life cognitive and brain imaging outcomes, controlling for
demographics (e.g., age, race/ethnicity and SES), site, neighborhood SES, and population density. Imaging
outcomes will be divided by intracranial volume prior to regression to account for differences in brain size.
Effect modification by the individual and neighborhood characteristics (Aims 2 and 3) will be tested using
interaction terms in adjusted models. The ultimate goal of this research is to provide evidence of neighborhood
environments that can be promoted to prevent cognitive decline, delay AD onset, and allow aging in place.

Public health relevance
PROJECT NARRATIVE This study will evaluate if during midlife (from ages 45-54), residing in greener neighborhoods with more healthy vegetation will be associated in later life with better cognitive function, slower annual declines in cognition, and less brain atrophy, and whether the associations vary by individual and neighborhood characteristics. It will provide the strongest evidence to date on whether long-term greenness exposure in midlife affects late life brain health. The knowledge gained will contribute to our understanding of the potential effectiveness of future neighborhood greening interventions that target healthy lifestyles and exposures over the life course to reduce Alzheimer’s risk and promote aging in place.